Mechanisms of Peroxiredoxin 6 Endowed Protection in Alzheimer’s Disease

Project Summary
β-amyloid (Aβ) deposition is the main culprit in preclinical phase of Alzheimer’s disease (AD). Its rate conditions
severity of ensuing neurofibrillary degeneration and precipitates the onset of cognitive deficit. Identification of AD
associated variants in the TREM2 receptor, which render microglia defective in processing Aβ plaques, well
underscores the meaning of protective function glial cell play in Aβ proteostasis. Like microglia, astrocytes
respond to Aβ deposits by altering their phenotype and function, yet molecular mechanisms governing astrocytic
response and those underlying the cooperative cross-talk between astrocytes and microglia in countering Aβ
deposition remain ill-defined. In this proposal, we put forward a novel hypothesis that an astrocytic protein
Peroxiredoxin (PRDX) 6 plays a pivotal role in these two intertwined processes. PRDX6 has two independent
enzymatic sites endowing glutathione peroxidase (Gpx) and phospholipase 2 (PLA2) activities. PRDX6 is
abundantly expressed by alveolar epithelium and endothelial cells and it is responsible for repair of peroxidatively
damaged cell membrane lipids, phospholipid metabolism, and cellular signaling. In the CNS, PRDX6 is
expressed by astrocytes, and its role in neurodegeneration remains unexplored. Our hypothesis is based on
extensive preliminary data showing that hemizygous knock in of the overexpressing Prdx6 transgene in APP/PS1
mouse model promotes selective enticement of astrocytes to Aβ plaques and penetration of plaques by astrocytic
processes along with increased number and phagocytic activation of periplaque microglia. This effects
suppression of nascent plaque seeding and remodeling of mature plaques consequently curtailing brain Aβ load
and Aβ associated neuritic degeneration. Conversely, Prdx6 haplodeficiency attenuates astro- and microglia
activation around Aβ plaques promoting Aβ deposition and neuritic degeneration. Thus, our data evidence that
PRDX6 expression level in astrocytes circuitously modulates microglia function implying astrocyte-guided
microglia effect in Aβ proteostasis. Furthermore, our showing that upregulation of PRDX6 attenuates Aβ
pathology implies a novel disease modifying strategy for AD. Aim 1 of this application will use newly developed
APP/PS1 mice, which are homozygous for the overexpressing Prdx6 transgene and APP/PS1 mice with Prdx6
knockout to determine the extent of Prdx6 overexpression expedience and conversely consequences of Prdx6
deletion on Aβ deposition, periplaque astro- and micro- glia response, Aβ-associated neurodegeneration and
behavioral deficit. Aim 2 will dissect individual effects of Gpx and PLA2 functions on curtailing Aβ pathology
through crossing APP/PS1 mice with readily available Prdx6 mutant mice, in which selective point mutations
rendered either enzymatic site inactive. Aim 3 will employ transcriptomic approaches to identify molecular
pathways involved in astro/microglia cross talk, which we expect to be altered by manipulating Prdx6 expression
level in Prdx6 overexpressing and knockout mice. Transcriptomic approaches also will determine whether
PRDX6 modulates activation phenotype of astrocytes and microglia and regulates glia inflammatory response.

Public health relevance
Project Narrative This project investigates mechanisms underlying endowed protective effect of astrocytic protein Peroxiredoxin 6 against Aβ pathology, and expedience of upregulating Peroxiredoxin 6 expression as a therapeutic approach for Alzheimer’s disease. It also explores how astrocytes guide microglia to counter Aβ accumulation in the brain.